Intergenerational disadvantage and pediatric health disparities in acute respiratory illness and diarrhea

PROJECT SUMMARY
Global literature underscores that certain children and families are more likely to experience persistent
social and economic disadvantages often determined by their race, ethnicity, social group, or other socio-
demographic characteristics. Simultaneously, studies from diverse settings demonstrate unequal burdens of
disease and unequal access to timely, quality health services in early childhood, contributing to lifelong health
disparities. However, few studies have available data to examine the distinct ways that intergenerational
disadvantage contributes to disparities in illness burden and healthcare utilization among children under five
when morbidity and mortality risk are high. We address a critical gap in the research by estimating the
association of persistent intergenerational disadvantage and diarrheal disease and acute respiratory infection
(ARI), with attention to the role of persistent disadvantage in determining the likelihood and type of healthcare
received, and potential modification by spatial remoteness.
We use data from a longitudinal study of households that includes data on young children and their
parents, households, and communities. The availability of detailed, high-frequency measures of the incidence
and duration of diarrheal disease and ARI in combination with data on household and community context and
health services over time provides a unique opportunity to study these questions with three specific aims. The
first aim uses newly collected data about experiences of diarrheal disease and ARI among children under five
years of age to estimate the association between persistent disadvantage and children’s illness burden. The
second aim estimates the association between the burden of diarrheal disease and ARI and the likelihood and
characteristics of healthcare utilized. This aim also tests whether this association is modified by persistent
household disadvantage. The third aim investigates the roles of spatial remoteness, distance to health ser-
vices, and persistent household disadvantage as modifiers of the association between the burden of diarrheal
disease and ARI, and the likelihood and type of healthcare facility utilized. We will archive and disseminate all
data collected to facilitate innovative research on social and structural determinants of child health and
healthcare utilization outcomes, and inform child health and health equity programs globally.
The effects of persistent, intergenerational social and economic disadvantage are increasingly important
considerations for providers and policymakers seeking to improve children’s health and health service
utilization, and to reduce health disparities that emerge in early childhood. This research will enhance our
understanding of the mechanisms through which exposure to persistent disadvantage shapes the health and
illness burden among young children; identify promising avenues for future research in this area; and generate
rigorous evidence for effective child health policies and interventions.

Public health relevance
PROJECT NARRATIVE This project seeks to document the frequency and duration of diarrheal disease and acute respiratory infection in early childhood, and assess how intergenerational disadvantage and household and community circumstances shape disparities in children’s health, illness, and healthcare utilization. The results of this project will allow child health programs and health systems to better address health disparities in illness and healthcare utilization among young children, and inform our understanding of the consequences of intergenerational disadvantage for children globally.